Project 1: Brain steroid receptor coactivators and energy homeostasis

Project 1 -­ Project Summary

Numerous nuclear receptors (NRs) or transcription factors (TFs) have been identified as important regulators of
body weight. However, anti-­obesity regimens targeting these individual molecules alone are far from satisfying.
Coactivators interact with a broad range of NRs/TFs and may serve as master regulators that coordinate and
synergize actions of multiple metabolic signals. High levels of Steroid Receptor Coactivator-­1 and -­2 (SRC-­1 and
SRC-­2) are expressed in the hypothalamus, the key brain region controlling feeding and body weight balance.
The pilot observations led to a hypothesis that hypothalamic SRC-­1 and SRC-­2 coactivate STAT3 and FoxO1,
repectively, to provide coordinated control of energy metabolism. Aim 1 will determine whether hypothalamic
SRC-­1 fine-­tunes STAT3 transcription activity to mediate the anti-­obesity effects of leptin. Mouse models lacking
or overexpressing SRC-­1 only in leptin-­responsive neurons have been generated. Metabolic parameters in
response to different diets or to leptin treatment will be assessed in these mice. Importantly, the molecular
mechanisms by which the SRC1-­pSTAT3 complex regulates leptin signaling will be delineated. Aim 2 will
determine whether human SRC-­1 mutations impair leptin-­STAT3 pathway in the hypothalamus and cause
obesity. Using the CRISPR technology, a knockin mouse line has been generated to mimic a SRC-­1 genetic
mutation associated with human obesity. Metabolic phenotypes of these mice will be characterized, and leptin-­
STAT3 actions and STAT3 transcription activity will be evaluated. Aim 3 will determine whether hypothalamic
SRC-­2 coativates FoxO1 transcriptional activity to facilitate energy reservations. Mice lacking or overexpressing
SRC-­2 in mature POMC neurons have been generated, with/without FoxO1 overexpression. Metabolic
phenotypes will be characterized in all these models and FoxO1 transcriptional activity will also be evaluated.

Public health relevance
Project 1 - Project Narrative STAT3 and FoxO1 are known to regulate body weight through their actions in the brain hypothalamus, but the molecular mechanisms underlying their functions remain to be elucidated. Using state-of-art technologies, we propose to determine whether two signaling molecules, namely Steroid Receptor Coactivator-1 and -2 (SRC-1 and SRC-2), interact with STAT3 and FoxO1, respectively, in the brain hypothalamus to regulate body weight balance, and therefore results from these studies will provide rational targets for the development of novel therapies for obesity.